Flow Cytometry Shared Resource

FLOW CYTOMETRY SHARED RESOURCE (FCSR): ABSTRACT
The University of Kansas Medical Center (KUMC) Flow Core was founded through an NIGMS-funded COBRE
program (P20RR016443/P30GM103326) in 2006. The Flow Core quickly grew to be an essential component
of the infrastructure of the KUMC research community, as well as The University of Kansas Cancer Center
(KUCC). With over one-third of Core users being Cancer Center members, the Flow Core was elevated to a
Cancer Center Shared Resource in 2018 after review by Matthew Mayo, PhD, MBA, FASA, Associate Director
for Shared Resources. and Cancer Center leadership. The mission of the Flow Cytometry Shared Resource
(FCSR) is to provide access to state-of-the-art flow cytometry and related technologies to all KUCC members.
The FCSR is led by the Scientific Director, Mary Markiewicz, PhD (CB), and maintains two-full time staff, a
Technical Director, Richard Hastings, MS, and a Research Assistant, Tykeemi Manor, BS. The FSCR houses
a BD LSR II and Attune NxT for cell analysis and a BD FACSAria IIIu for cell sorting. In addition, the FCSR
houses a Luminex 200 for multiplex analysis of cytokines, chemokines, and other small molecules. The FCSR
aids investigators in experimental design, protocol development, sample preparation, data acquisition, and
data analysis. Additionally, the FCSR has strong procedures in place for quality assurance, training,
scheduling, data storage, and data analysis. Over the past three years, the FCSR provided key services in
support of 25 publications to KUCC members (five papers ≥ 10 journal impact factor), 41 unique users, and
four NIH/NIGMS/NCI grants, one DOD grant, and four private foundation awards, and was essential to analysis
of human samples for correlative studies from an NCI-funded clinical trial (R37CA218118, NCT01868087). In
the reporting year (2020), the FCSR supported 34 different users (28 KUCC members from all three research
programs, of which 75% were funded and six non-members). The proposed budget of the FCSR (Year 11) is
$283,970, yet the CCSG request is $15,014. As such, the FCSR leverages grants, contracts, user fees, and
extensive institutional support and seeks only 5% support from CCSG funds.